Early Age-Related Hearing Loss Investigation (EARHLI): A Randomized Controlled Trial to Assess Mechanisms Linking Early Age-Related Hearing Loss and Alzheimer's Disease and Related Dementias

PROJECT SUMMARY/ABSTRACT
This proposal is an early phase II randomized controlled trial (RCT) to obtain preliminary data on mechanisms
and efficacy of a hearing aid-based intervention to prevent cognitive decline in those at risk for Alzheimer’s
Disease and Alzheimer’s Disease Related Dementias (AD/ADRD). The target risk group is 55-75-year old people
with early-stage age-related hearing loss (ARHL) and amnestic mild cognitive impairment. The RCT, entitled
“Early Age-Related Hearing Loss Investigation (EARHLI)” is in response to PAR-18-877, “Early Stage Clinical
Trials for the Spectrum of Alzheimer’s Disease and Age-related Cognitive Decline.” ARHL, the third most
common chronic condition in later life, is associated with cognitive impairment/AD/ADRD. This finding has
recently been extended to early ARHL (borderline-to-moderate hearing loss [20-55 dB] on pure tone audiometry),
which is rarely treated with hearing aids. The mechanisms linking ARHL and AD/ADRD are unknown, but
reduced social engagement and changes in brain organization/connectivity have been proposed. A 2020 Lancet
Commissions report estimated that eliminating ARHL could be associated with an 8% reduction in new dementia
cases, at least as much as well-established risk factors. Yet, 90% of the target population is not treated with
hearing aids and there is a dearth of RCTs testing the efficacy of hearing aids in ARHL. While studies have
suggested hearing aids improve social engagement, brain organization/connectivity, and, in turn, cognition, there
is no RCT evidence supporting these observations. There is one ongoing RCT (ACHIEVE, ClinicalTrials.gov
NCT03243422) examining the effect of a hearing intervention on cognition in older adults with more advanced
ARHL. EARHLI focuses on early ARHL in middle and early older age, a critical time for AD/ADRD prevention.
Unlike ACHIEVE, EARHLI also measures brain organization/connectivity. EARHLI will be a phase II 1:1 RCT of
a hearing aid-based intervention versus a comparator (health education program) conducted over 12 months in
150 participants (n=76 undergoing MRI) with early ARHL at risk for AD/ADRD. The overarching hypothesis is
that the hearing intervention will lead to improved social engagement and brain organization/connectivity that
will lead to improved cognition compared with the comparator arm. This hypothesis will be tested with an intent-
to-treat approach comparing the hearing intervention and comparator arms. Aim 1 is to compare change in
cognitive performance measured with the Alzheimer’s Disease Cooperative Study Preclinical Alzheimer
Cognitive Composite (ADCS-PACC; 1º outcome) and by domain-specific cognitive testing on ADCS-PACC
components (0, 6, 12 months). Aim 2 is to compare change in social engagement measured by activity
participation (1º outcome) and network size/support (at 0, 6, 12 months). Aim 3 is to compare changes in brain
organization/connectivity using task (visual task, auditory regions of interest,1º outcome) and resting-state fMRI,
and diffusion-weighted structural connectivity (at 0, 12 months). We will explore whether social engagement and
brain organization/connectivity mediate the effects of the intervention on cognitive outcomes.

Public health relevance
PROJECT NARRATIVE Our project aligns with the National Alzheimer’s Project Act to “prevent, halt, or reverse Alzheimer’s disease.” It is responsive to PAR-18-877 to “develop and implement early stage (Phase I or II) clinical trials of promising…non-pharmacologic interventions” including “in individuals with…presymptomatic…stages of disease.” Because age-related hearing loss is highly prevalent, uncommonly treated, and recognized as a major risk factor for Alzheimer’s disease and related dementias, this project is of high public health significance and potential high impact.